Neuromodulatory control of prefrontal circuit function and reward-seeking

Project Summary / Abstract
Depression is a fundamentally episodic condition, but the mechanisms mediating mood state transitions are
not well understood. In our prior work, we investigated how stress and antidepressant effects on synaptic
remodeling influence changes in reward-seeking behavior and anhedonia, a core feature of depression. We
found that synaptogenesis in prefrontal cortex (PFC) is required for sustaining antidepressant effects on
behavior but not for initiating them. Here, we will investigate the molecular, cellular, and circuit-level
mechanisms that initiate antidepressant effects on effortful reward-seeking and how they interact with
synaptogenesis to generate durable changes in behavior. PFC circuits support reward-seeking behavior by
mediating effort valuation computations, which integrate information about the magnitude of an anticipated
reward and the expected effort required to obtain it. We have shown how nucleus accumbens (NAc)-projecting
PFC cells encode and integrate information about reward- and effort-predictive cues and are critical for
reinforcing decisions to expend effort to obtain rewards. We will test a model based on extensive preliminary
data in which G protein-coupled receptor (GPCR) signaling in somatostatin (SST) interneurons initiates rapid-
acting antidepressant effects on circuit function and behavior. Our efforts will leverage newly developed
photopharmacological tools for manipulating GPCR signaling in specific circuit elements with unprecedented
spatiotemporal precision, in conjunction with state-of-the-art 2P imaging and optogenetic tools for visualizing
and manipulating spine dynamics and circuit function in the living PFC. Our central hypothesis is that Gi/o
activation in SST cells initiates antidepressant effects on effortful reward seeking by disinhibiting PFC-NAc
cells, restoring coordinated activity in PFC circuits and their capacity to encode reward- and effort-related
signals. This, in turn, leads subsequently to the formation of new synapses, which are required for sustaining
antidepressant effects over time. Finally, we will test a strategy for identifying SST-enriched Gi/o-coupled
GPCRs and validating the most promising candidates as novel therapeutic targets, enabling synergistic effects
on effortful reward seeking and anhedonia. Successful completion of our aims will open new avenues for
developing synergistic treatment strategies that converge on disinhibition of PFC projection neurons and
restoration of lost synapses in specific circuits.

Public health relevance
Project Narrative Depression is a leading cause of disability, and for many individuals, existing antidepressants are slow to relieve symptoms or do not provide lasting benefits. This project will investigate the molecular and circuit-level mechanisms by which antidepressants act to reverse the effects of chronic stress on reward-seeking behavior, and how these effects are sustained over time. Our studies will advance our understanding of how the brain integrates information about rewards in our environment and the effort required to obtain them, and will potentially open new avenues for identifying novel treatment targets for anhedonia in depression.